ACTIV-1 TIME-LIMITED BIOSPECIMEN STORAGE AND RELATED SERVICES (COVID-19), OPTION QUANTITY 1 STATISTICAL SUPPORT, OPTION QUANTITY 2 BIOSPECIMEN ANALYSI

CRO Assistance for Long-term Storage, Distribution and Analysis of Biospecimens from the ACTIV-1 Master Protocol, an adaptive Phase 3 clinical trial to evaluate the safety and efficacy of three immune modulator drugs in hospitalized adults with COVID-19.